RDCRC Administrative Core

Abstract
The Administrative Core is designed to ensure efficiency in the development, dissemination and
application of new knowledge obtained by the Inherited Neuropathy Consortium (INC) RDCRC.
The Central Administrative Core (CAC) is responsible for the overall administration of the INC
and will oversee and coordinate interactions between the various components and projects of
the INC. To achieve this goal, the CAC is comprised of Professor Michael Shy as the Director of
INC RDCRC, Professor Steven Scherer as the Administrative Director, Professor David
Herrmann as Clinical Liaison to the INC, Ms. Shawna Feely and Ms. Chelsea Bacon, as Clinical
Coordinator and Assistant Clinical Coordinator. The Internal Advisory Board (IAB) will interact
directly with the CAC on monthly conference calls. The IAB includes site PIs, the five INC
Patient Advocacy Groups (PAGs), the INC Chief Biostatistician and DMCC representatives. We
have added an International Liaison, a Diversity Liaison and Clinical Trial Committee to interact
with the IAB. Finally, we will continue to interact with the INC External Advisory Committee
(EAC) which is composed of internationally recognized investigators, PIs from additional
RDCRC and representatives of the INC PAGs.

Public health relevance
Project Narrative Per RFA – do not complete.